The Promoting Resilience in Stress Management (PRISM) Intervention: a multisite randomized control trial in adolescents with Type 1 Diabetes

PROJECT SUMMARY As an underrepresented, first-generation, minority student, the first of my family to attend college, I have already harbored many personal and professional experiences that have fueled me with the passion and drive to continue to work towards a long-term career goal in clinical research. Specifically, I strive to obtain my Masters in Public Health, focusing on improving health outcomes for marginalized communities. The learning goals proposed in this diversity administrative supplement, supported by my proposed, experienced mentor Dr. Joyce Yi-Frazier, will optimally position me for success in this career trajectory. Dr. Yi-Frazier’s parent proposal is an R01 examining the efficacy of an intervention for youth with type 1 diabetes. Given the timeline of the R01, I will be able to participate in many impactful ways. The learning goals are to: 1) gain clinical research coordinator experience, 2) learn to analyze and present data, and 3) conduct a deep-dive into the understanding of pediatric mental health interventions, specifically related to health outcomes and minority health. I will be supported by Dr. Yi-Frazier and Drs. Faisal Malik and Marisa Hilliard to help meet these goals. This supplement will significantly strengthen my experiences as a researcher and position me for a future career in research.

Public health relevance
PROJECT NARRATIVE The parent grant for this administrative supplement (R01DK121224) seeks to explore the efficacy of a resilience-promoting intervention to improve A1C and reduce diabetes distress for adolescents with type 1 diabetes. The proposed administrative supplement will aid the progress and success of the parent grant while also providing a critical learning opportunity for Ms. Samantha Garcia Perez, who will be supported with a strong mentorship team covering three primary learning areas: 1) to gain clinical research experience, 2) to analyze and present qualitative and quantitative data, and 3) to obtain specialized training in youth mental health measurement and intervention science. These areas will facilitate Ms. Garcia Perez’s longer-term goal of specialized intervention programs for marginalized populations.